Development of Cellular HTS for 20S Proteasome Enhancers

There are still no effective treatments for neurodegenerative diseases, including Parkinson’s disease (PD),
Alzheimer’s disease (AD) and Alzheimer’s related dementias (ADRD). One major obstacle in finding small
molecules capable of combatting these synucleinopathies and tauopathies is that the proteins that mediate
these disorders are structurally unfolded (i.e. intrinsically disordered). In addition to their tendency to aggregate
upon accumulation, intrinsically disordered proteins lack defined binding pockets, thus they have largely
evaded traditional drug discovery design efforts. However, recent studies found that enhancing proteasome
activity can prevent toxic accumulation of intrinsically disordered proteins (such as α-synuclein and tau
species), reduce brain damage and prevent AD related dementia. Of the different proteasome complexes,
only the 20S proteasome targets intrinsically disordered directly for degradation. Unfortunately, the
translational exploration of this entirely new therapeutic strategy has been limited due to (1) the lack of a
suitable cellular assay to identify 20S proteasome enhancers and subsequently, (2) lack of drug-like small
molecule 20S proteasome enhancers.
This grant will directly address these two voids that currently prevent the exploration of this new therapeutic
strategy to treat PD, AD and ADRDs. In the R61 phase, we will develop and validate the first cellular and
physiologically relevant high throughput screening (HTS) assays with the goal to broaden the portfolio of small
molecule drug-like enhancers of the 20S proteasome. In the R33 phase, we will optimize the efficacy and
physiochemical properties of two select series from that screen to generate the first suitable agents for the
translational exploration of this new approach.
Successful completion of this work will provide a robust platform to identify and develop suitable drug-like
candidates to explore the translational potential of this new therapeutic approach for treating Parkinson’s
disease, Alzheimer’s disease and Alzheimer’ related dementias.

Public health relevance
Recent ground breaking studies found that enhancing proteasome activity prevents the toxic accumulation of intrinsically disordered proteins, such as tau-species (implicated in the pathogenesis of Alzheimer’s disease, AD) and α-synuclein-species (implicated in the pathogenesis of Parkinson’s disease, PD), resulting in reduced brain damage and prevention of AD related dementias (ADRD). Unfortunately, small molecules that enhance 20S proteasome activity are extremely scarce because there are no suitable methods to identify them in cell culture, which has prevented the exploration of this new and possibly game-changing therapeutic paradigm. The objective of this work is to develop a robust cellular HTS screening assay to identify (R61) and develop suitable drug-like candidates (R33) that enhance the proteolytic activity of the 20S proteasome to provide tools to explore the translational potential of this new therapeutic approach for treating Parkinson’s disease, Alzheimer’s disease and Alzheimer’ related dementias.